Studies of Global Signal Transduction

Abstract: Research in my laboratory has centered on the development and application of multi-disciplinary
approaches to study signal transduction pathways important in normal physiology and, when de-regulated,
contribute to a number of diseases. This began with our discovery and cloning of a novel signaling partner for
the epidermal growth factor receptor, the human Cdc42 protein, a small GTPase highly conserved from yeast to
humans, and continued with the identification of many Cdc42 regulatory proteins and signaling targets. The
conservation of Cdc42 throughout evolution accounts for the many fundamentally important roles it plays in cell
biology and organism development, including the regulation of cell growth and migration, and the establishment
of cellular polarity. We then discovered an unanticipated but highly significant function of Cdc42 in directing the
upregulation of glutamine metabolism and metabolic activities that generate building blocks for biosynthetic
processes required in a wide range of cellular functions. This also provides a mechanism for connecting the
various intracellular processes regulated by Cdc42 to the surrounding environment by directing the biogenesis
of extracellular vesicles (EVs), which have been implicated by our laboratory and others in mediating intercellular
communication across the evolutionary spectrum from bacteria to higher organisms. Recently, we found that
Cdc42 activates these metabolic activities through the assembly of large protein complexes. Understanding how
these metabolic/signaling nodes are assembled holds important clues to their regulation and function, as well as
sheds light on a long-standing question of how Cdc42 activates a critically important protein kinase, mTOR
(mechanistic Target of Rapamycin), which is a necessary step for cap-dependent mRNA splicing, the neuronal
differentiation of embryonic stem cells (ESCs), and the survival of cancer cells under stressful conditions.
Elucidating the biochemical and structural features of these large complexes that activate glutamine metabolism
and mTOR, which are essential for cell growth and survival, and helping to move forward the field of EVs
represent major research goals for our laboratory in the next 5 years. Key gaps in our knowledge surrounding
these broad areas of study will be addressed. We want to understand how Cdc42 directs the formation of
metabolic/signaling nodes that not only play such important roles in cell biology but also have significant
implications for disease, define the mechanisms responsible for their regulation, and determine their 3D
structures. We also will set out to address challenging questions to further the development of the EV field, by
identifying the biochemical determinants and signaling cues that dictate the loading of essential EV cargo and
determining the structural features of EVs that enable their various biological functions. To achieve these goals,
we will leverage our expertise in signal transduction and benefit from a strong group of collaborators.

Public health relevance
Project Narrative The efforts of my research program have been directed at probing the actions of membrane receptors and their G protein signaling partners that influence cell growth, differentiation, and development. These studies have culminated in a series of exciting new discoveries that describe how these signal transduction pathways are linked to the assembly of multi-protein complexes that regulate the metabolic activities of cells and the biogenesis of extracellular vesicles, important in embryonic stem cell function, differentiation, cellular senescence and aging, cancer, and infectious disease. By probing the signaling mechanisms that regulate these metabolic complexes and the biogenesis and function of extracellular vesicles, together with elucidating their structural features, we expect to gain new insights into the critical roles they play in a broad spectrum of biology and disease, as well as highlight new targets and strategies for therapeutic intervention.